Glial Involvement in REDOX Homeostasis in the Substantia Nigra

PROJECT SUMMARY
Controversies exist regarding the contribution of glial cell dysregulation and inflammation to the pathogenesis
of Parkinson Disease (PD). Signs of inflammation have been detected in postmortem tissue of PD patients, and
recent evidence suggests that mutations in genes associated with familial PD can influence the function of
astrocytes and microglia. These findings, together with the existence of mutations in the HLA locus in PD
patients, have led investigators to propose an etiological role for inflammation and glial dysfunction in PD.
However, direct evidence is lacking for mechanistic links among inflammation, glial dysregulation, and the
neuronal loss characteristic of PD.
To identify potential cell-autonomous mediators of PD-relevant processes in glia, we used a bioinformatics
strategy to identify PD GWAS genes enriched in glial cells of the mouse brain. Interestingly, a small subset of
genes exhibits enrichment of expression in astrocytes. PD-linked single-nucleotide polymorphisms in one of
these genes, CD38, are associated with a ~45% reduction in CD38 transcript expression in the human brain.
Previous work has demonstrated a role for CD38 in peripheral immune cells, where it serves to regulate REDOX
balance in both intra- and extra-cellular compartments; the roles for CD38 in the brain have only recently been
explored. Preliminary experiments from our laboratory have shown that CD38 expression is enriched in
astrocytes of the human and mouse brain, NAD/NAM balance is disrupted in various regions of the CD38
knockout mouse brain, and inflammation and CD38 deficiency synergistically interact to influence motor function.
Here, we propose to use CD38 as a prototypical gene to understand ways in which glial dysfunction can give
rise to a PD-like phenotype in mice by investigating 1) the requirement for CD38 in the maintenance of REDOX
homeostasis and dopaminergic neuron function and viability in aging mice, 2) the role for CD38 in the regulation
of inflammation in the substantia nigra, and 3) the impact of CD38 modulation on the vulnerability of dopaminergic
neurons in two synucleinopathy mouse models of PD. A subset of experiments will test the involvement of
REDOX dysregulation in the changes observed in CD38-deficient mice by determining whether provision of
nicotinamide riboside, a bioavailable NAD precursor, can prevent dopaminergic oxidative stress, cell dysfunction,
and loss. Altogether, these experiments have the potential to reveal mechanistic contributors to increased
neuronal vulnerability with glial dysfunction and provide novel information about the roles for glia in maintaining
dopaminergic neuron survival in aging and disease.

Public health relevance
PROJECT NARRATIVE Parkinson Disease (PD) is a progressive movement disorder characterized by the dysfunction and loss of neurons which release the neurotransmitter dopamine. Recent evidence suggests that abnormalities in non- neuronal cells in the vicinity of dopaminergic neurons can influence their survival. The experiments in this proposal aim to determine the mechanisms by which a glial-enriched PD-risk gene influences dopaminergic viability, giving novel insight into the pathways by which glia support dopaminergic neuron survival in health and disease.